IDENTIFICATION OF THE LPS RECEPTOR ON HUMAN MONOCYTES

Lipopolysaccharide (LPS) is a common component of gram negative bacteria cell walls which acts as a potent inducer of cytokine release from human monocytes. The purpose of this project is to isolate and identify the protein(s) on human monocytes which bind LPS and initiate the release of cytokines from these cells. Using sepharose beads which have been covalently crosslinked with LPS, we have isolated two proteins from human monocytes lysates, which appear to bind specifically to the LPS coated beads and not the control beads. The molecular weight of these proteins are approximately 73 and 85 kd. The 73 kd protein appears to be present in greater abundance. Two other groups, using different techniques, have likewise isolated a protein of approximately 73 kd which appears to bind LPS. Currently, using Western blot analysis, we have tentatively identified the 73kd protein as a breakdown product of ezrin and the 85 kd protein as a minor heat shock protein. In addition, we~ve found a monoclonal antibody, produced by Dr. David Morrison~s group to a 73kd LPS binding protein they isolated, appears to react with the same protein we've identified as ezrin.